EFFECT OF RO 40-5967 IN COMPARISON WITH PLACEBO IN PATIENTS WITH CHF

To evaluate the safety and clinical response of a new calcium antagonist compared to placebo in patients with impaired cardiac function.